Anti-IL-12p40 Treatment of CVID Enteropathy: Gene Expression/Microbiota Analysis

DESCRIPTION (provided by applicant): Common variable immunodeficiency (CVID) is the most common symptomatic primary antibody deficient syndrome and is characterized by decreased levels of serum immunoglobulins and recurrent sinopulmonary infections. In addition, up to 50% of patients manifest a non-infectious malabsorption syndrome, also known as CVID enteropathy, that is usually resistant to treatment. The pathogenesis of CVID enteropathy is still unclear, but recent studies have suggested that it results from a complex interaction between the gut microbiota and the intestinal epithelium leading to a hyperactive mucosal immune response characterized by increased production of Interleukin-12 and Interferon-gamma. Further work in a mouse model of this enteropathy demonstrated that in the presence of microbiota but not in germfree animals, intestinal epithelium of immunodeficient hosts upregulates interferon-dependent immune genes at the expense of metabolic genes. In addition, preliminary microarray analysis CVID patient tissue revealed a similar dysregulation of gene expression in human CVID. We propose that selective inhibition of the hyperactive mucosal immune response would correct the gene imbalance and resolve the malabsorption in CVID patients. Ustekinumab is a monoclonal antibody to the p40 subunit of interleukin-12/23. It is approved for the treatment of psoriasis, and is currently being evaluated in Phase III trials fo the treatment of refractory Crohn's disease. We propose to treat CVID enteropathy patients with ustekinumab and assess the effects on clinical and immunologic parameters as well as on gene expression. Response to therapy will be assessed by evaluation of the degree of malabsorption, histological alterations in gut biopsies, cytokine production and global gene expression in blood, gut biopsies and isolated intestinal mononuclear cells. Changes in intestinal microbial composition in gut biopsies will be monitored using metagenomic analysis of shotgun sequencing data and correlated with clinical and immunological parameters to define microbes possibly driving the hyperactive immune response. These studies will therefore provide a unique opportunity to perform an evaluation of a novel therapy of CVID enteropathy while at the same time conducting studies defining the mechanisms underlying CVID enteropathy under dynamic conditions.

Public health relevance
PUBLIC HEALTH RELEVANCE: In this study we will test the efficacy of a novel medicine (ustekinumab) for enteropathy associated with common variable immunodeficiency. Besides finding a solution for patients who currently do not have efficient treatment, this study will also study key microbial and molecular aspects of this disorder providing insights into host-microbe interaction in the gut and contributing to future successes in management of other gut diseases. __SpecificAimsTextDelimiter__ Specific Aims Common variable immunodeficiency (CVID), the most common symptomatic primary antibody deficiency, is primarily a B cell disorder characterized by decreased levels of serum immunoglobulins and recurrent sinopulmonary infections. However, the disease may also be accompanied by any of several other disorders or immune dysfunction including a gastrointestinal syndrome known as CVID enteropathy. The latter occurs in up to 50% of patients and is a non-infectious complication of the GI tract marked by the presence of villous atrophy and its sequelae of nutrient malabsorption, steatorrea, and low body mass (1, 2). Corticosteroids are the only effective therapeutic agents, but their use in patients with pre-existing immunodeficiency is risky. Our previous studies of CVID enteropathy have revealed that patients with this syndrome exhibit abnormal mucosal Th1 immune responses characterized by greatly increased production of IL-12 and IFN-g but no increase in IL-23 and IL-17 (2). In addition, our work in mouse models showed that B cell-deficient mice living in a specific pathogen-free environment exhibit up-regulation of both type I and type II interferon-dependent genes at the expense of metabolic genes whereas the same mice living in a germ-free environment do not manifest this skewed profile. A similar gene expression signature was found in studies of a limited number of patients with CVID in spite of the fact that these patients do not usually exhibit bacterial over-growth (3). While informative, the above studies leave many questions concerning CVID enteropathy unanswered. In particular, they do not define which microbes, if any, are playing a pathogenic role and whether the Th1 T cell response associated with the syndrome is primary or secondary to a microbial dysbiosis. Also, they do not define the relation between the excessive Th1 response and the underlying shift in gene expression to interferon-dependent genes. In studies described in this Proposal we plan to take a two-pronged approach to the further study of CVID enteropathy that will address the above unanswered questions. The first prong will consist of a pilot study of the use of anti-IL12p40 as a treatment of CVID enteropathy using a monoclonal antibody (Ustekinumab) that has already been approved for the treatment of psoriasis(4). This pilot study of anti-IL12p40 will potentially provide a new treatment of CVID enteropathy and, when combined with studies of the intestinal microbiota, will allow us to determine if the microbial dysbiosis is secondary to the T cell immune dysfunction or is independent of the latter. The second prong of the proposed study consists of a molecular analysis of the intestinal microbiota in the upper intestine of CVID patients combined with a global assessment of gene expression in CVID duodenal lamina propria tissue. These studies have the potential of pinpointing the microbes that lead to enteropathy as well as the gene expression imbalance. Aim 1: Evaluation of anti-IL12/23p40 in the treatment of CVID enteropathy. Based on our prior work showing that CVID enteropathy is characterized by an excessive mucosal Th1 cytokine response, patients with enteropathy will be treated with an appropriate dose of ustekinumab (anti-IL- 12p40) and response to therapy will be monitored by clinical and immunological parameters such as the persistence of villous atrophy in duodenal biopsies, and cytokine production before, during and after treatment. Aim 2: Molecular analysis of intestinal microbiota and global gene expression in CVID enteropathy. 2.1: Our preliminary work identified expression profiles of metabolic and interferon type I- and type II-related genes in CVID enteropathy. In the proposed studies we will compare these profiles in CVID patients with and without enteropathy (and control patients) to determine the relation of the enteropathy and the underlying B cell dysfunction to gene expression. Furthermore, we will determine the impact of anti-IL-12 treatment on gene expression. These studies will provide insight into the question of whether repression of an IFN type II response is sufficient to restore the imbalance in gene expression. 2.2: Using a murine model of CVID enteropathy we previously demonstrated that microbiota are necessary for the development of immune and metabolic alterations in the gut of the mice. In order to identify, in humans, microbes with a potential causal role in CVID enteropathy we will examine bacterial and viral components of microbiota using state of the art metagenomics analysis. First, we will identify microbes enriched in enteropathy comparing to non-symptomatic CVID patients and healthy controls. Next, we will correlate microbes with clinical/molecular parameters to define microbes possibly driving the enteropathy. Finally, we will compare microbe profiles before and after treatment with anti-IL12 to determine if the dysbiosis is primary or secondary to the Th1 disorder. In summary, this Proposal exploits a unique opportunity to evaluate a novel therapy of CVID enteropathy while at the same time conducting studies defining the mechanisms underlying CVID enteropathy. This work will bring together the extensive expertise in clinical mucosal immunology of the intramural part of our team and the strengths of the extramural part in the analyses of complex genomic data from patients. Finally, it will take advantage of the large cohort of CVID patients currently being followed at the NIH Clinical Center.